Mechanisms of nematode molting

Project Summary
In this MIRA proposal we will gain insight into how biological timers control development and how the apical
extracellular matrix (aECM) is constructed and remodeled. How biological timers control human development is
only beginning to be understood. Animal development requires precise temporal synchronization of a broad
range of events controlled by developmental clocks. In contrast to the circadian clocks that enable animals to
anticipate daily cycles of light, temperature, and other environmental variables, the properties, components, and
wiring of these developmental timers is only beginning to emerge. Examples of these timers include the clocks
that control somite formation and hair follicle cycling. We use C. elegans as a model to understand developmental
timers function. Two independent but interconnected biological timers drive progression through C. elegans
development. The heterochronic pathway is a linear timer that controls the serial progression of stage-specific
cellular events. A cyclical molting timer coordinates apical extracellular matrix regeneration and shedding of the
old cuticle. Understanding these timers will inform how animals transition from juveniles to adults, how cell fate
and cell divisions are coordinated with linear developmental progression, and how a dynamic aECM is built
during development. Aberrant aECM function has been implicated in a variety of human diseases and defects
can impact hearing, wound healing, the skin barrier, and cardiovascular and renal function. Despite extensive
study of aECMs in many organisms, we know little about their molecular organization. C. elegans is an ideal
model system in which to address these knowledge gaps because it is transparent with a new aECM being built
each larval stage over a course of 8-10 hours making it possible to perform real time imaging of aECM formation.
In addition to informing human biology, we are also interested in nematode-specific biology, as it offers an
intervention point to combat parasitic nematode infections. As a group, these animals afflict an estimated 1.5
billion people worldwide, comprising approximately 85% of global neglected tropical diseases. They also threaten
food security by infecting crops and livestock. Our long-term goal is to define the mechanisms that ensure faithful
molting at the molecular, cellular, and organismal level in C. elegans and then extend our work into parasitic
nematode models with the goal of uncovering vulnerable processes for future therapeutic targeting This work
involves three projects. In the first 1 we will determine how biological timers control development, focusing on
NHR-23, LIN-42, and KIN-20. In the second project, we will test whether NHR-23 is ligand regulated to control
molting. In the third project we will determine how the aECM is formed and remodeled during development,
focusing on the role of proteases and protease inhibitors. Our hypothesis is that each protease inhibitor has a
cognate protease that it regulates to ensure that the protease is only active at a specific time and location.

Public health relevance
Project narrative The proposed studies will impact public health in two areas. Understanding conserved processes such as how biological timers coordinate development and how the apical extracellular matrix is built and remodeled will provide insight into human disease. Nematode-specific mechanisms we uncover are strong candidates to target for developing therapeutics against parasitic nematodes, pathogens which infect over one billion people and threaten food security through infesting livestock and crops.